Zambia Alabama HIV Alcohol Comorbidities Program (ZAMBAMA)

Zambia Alabama HIV Alcohol Comorbidities Program (ZAMBAMA)
The overall aims of the Zambia Alabama HIV Alcohol Comorbidities Program (ZAMBAMA) are to (Aim 1) test the effectiveness of a transdiagnostic model, Common Elements Treatment Approach (CETA), to reduce unhealthy alcohol use and improve HIV clinical outcomes in rural and not yet reached HIV clinics, (Aim 2) evaluate the mechanisms through which CETA impacts HIV outcomes, (Aim 3) investigate whether the treatment effect of CETA varies by clinical (e.g., presence of comorbidities), demographic (e.g., sex) and/or contextual factors (e.g., Zambia, Alabama), and (Aim 4) examine implementation factors, including cost, related to integrated delivery of alcohol reduction interventions to people with HIV and unhealthy alcohol use at front-line HIV clinics. The P01’s central theme is that, among people with HIV and unhealthy alcohol use, integrated screening and treatment of common behavioral and mental health comorbidities will lower unhealthy alcohol use and improve HIV treatment outcomes. ZAMBAMA will be implemented by a collaborative team that brings together groups of established and early-career investigators working to address scientific gaps at the nexus of HIV, substance use, and mental illness in priority geographical areas in the global HIV response: the region south of the Sahara Desert and the Southern U.S. Together, the team will implement two randomized controlled clinical trials in adults with HIV and unhealthy alcohol use to evaluate CETA’s effects on alcohol use, the HIV care continuum (antiretroviral therapy adherence, engagement and retention in HIV care, viral suppression), and common mental health and substance use comorbidities. Project 1 (CETA HIV Alcohol Reduction Trial in Zambia
- CHARTZ) will be implemented at public sector primary HIV clinics in Zambia where existing HIV ‘peer educators’ (i.e., lay counselors) will be trained to provide an alcohol brief intervention (BI) and CETA to participants at in-person sessions. Project 2 (Telemedicine for Unhealthy Alcohol Use in Persons Living with HIV using CETA - TALC) will enroll participants receiving HIV care at community Ryan White HIV/AIDS program- funded clinics across Alabama that are serving not yet reached and rural populations. Graduate-level providers (supervised by a licensed clinical psychologist) will provide the interventions (BI and CETA) remotely using telemedicine approaches that were rapidly expanded during the COVID-19 pandemic. Both research projects will also evaluate implementation factors, to enhance the impact of clinical effectiveness data and both projects will be supported by 3 resource cores: a CETA core for clinical intervention training and oversight, a Methods and Analysis core to harmonize data elements across projects and create synergy in data analyses, and an Administrative core to manage business and regulatory requirements of the P01, monitor and manage overall progress, and promote bidirectional knowledge and idea exchange between Southern U.S.- and the region south of the Sahara Desert-focused investigators.

Public health relevance
Zambia Alabama HIV Alcohol Comorbidities Program (ZAMBAMA) Unhealthy alcohol use represents an unaddressed barrier to achieving and maintaining control of the HIV epidemic globally. In the Zambia Alabama HIV Alcohol Comorbidities Program (ZAMBAMA), we will compare the effectiveness of an alcohol brief intervention and a transdiagnostic cognitive behavioral therapy-based model that can address unhealthy alcohol use and a range of comorbid mental health problems to improve HIV and alcohol outcomes among persons with HIV and unhealthy alcohol use in the region south of the Sahara Desert and the Southern United States. ZAMBAMA’s 2 research projects and 3 resource cores were designed for integration and synergy, which will not only strengthen our ability to address our specific aims but will also create unique scientific opportunities that would not be possible without a program structure.